Structural and biophysical studies of DNA topoisomerases

Project Summary Topoisomerases are ubiquitous proteins found across all three domains of life (bacteria, archaea, and eukarya). They are involved in several cellular processes and the importance of their cellular role is underscored by the fact that they are the target of several cancer chemotherapeutic agents and antibiotics. Topoisomerases change the topology of DNA by transiently breaking one (type I) or two (type II) DNA strands to allow passage of either a single or double DNA strand through the break or swiveling of one strand around the other. The study of the structure and function of topoisomerases promises not only to further our understanding of proteins that interact with DNA and alter its topological properties, but also to provide important information to aid in the design of new therapeutic agents. This proposal is concerned with biochemical, biophysical, and structural studies of different topoisomerases. The long term goal of the project is to provide a comprehensive understanding of topoisomerase action at many different length and time scales, from the atomic level to the nano scale. In the past period we made substantial progress towards this goal, including using single molecule methods to discover the role of pauses in the mechanism of type IA topoisomerases, characterizing the topoisomerase active site of topoisomerase V, solving the structures of 78 kDa and 97 kDa fragments of topoisomerase V containing one or two of the DNA repair sites, and discovering the presence of a third repair domain. In addition, we continue making progress on our work on a complex of gyrase with a large DNA fragment and also developed a new instrument that is capable of simultaneously manipulating single DNA molecules and reporting on movements of a protein by fluorescence. Our studies are providing important information on topoisomerases and allowing us to relate atomic structures to the wealth of existing functional, biochemical, and biophysical data. For the next project period we propose to continue and expand our studies of topoisomerases. The specific aims for this proposal are: i) to probe the mechanism of type IA topoisomerases by novel single molecule approaches, ii) to continue our structural and biochemical studies of topoisomerase V, and iii) to continue our structural and mechanistic studies of a gyrase/DNA complex. The work is based on a combination of molecular biology and biochemical methods to produce and characterize the macromolecules that we require for our work, X-ray crystallography and electron microscopy methods to solve their structures, and single molecule studies to elucidate their mechanism.

Public health relevance
Project Narrative We propose to study the structure and mechanism of DNA topoisomerases, enzymes that are involved in several cellular processes, such as transcription, replication and recombination. The importance of their cellular role is underscored by the fact that they are the target of several cancer chemotherapeutic agents and antibiotics. The long term goal of our work is to provide a comprehensive understanding of the mechanism of action of this ubiquitous family of enzymes at many different length and time scales.